Next generation transcranial ultrasound-based neuromodulation using phase shift nanoemulsions

Project Summary
This proposal responds to PAR-22-039 and aims to develop focused ultrasound (FUS) as a next
generation high precision device-based pharmacological neuromodulation tool and evaluate its use in non-
human primates as a translational step to humans. Current device-based neuromodulation technologies rely
on interaction with cells’ endogenous sensitivities to different forms of energy. Although FUS alone overcomes
spatial and depth limitations of other non-invasive neuromodulation modalities, the diverse response of cells to
FUS presents a limitation and can make predictable neuromodulation difficult. We seek to move beyond the
paradigm of modulating via endogenous sensitivity by developing FUS in combination with phase shift
nanoemulsions (PSNEs)—200 nm liquid particles that can carry a drug payload and become microbubbles
when exposed to brief (<1 msec) FUS pulses above a threshold. By developing FUS combined with PSNEs,
we will be able to predictably modulate millimeter-scale regions throughout the brain by either locally
enhancing blood brain barrier (BBB) permeability and injecting a drug or by releasing drugs from PSNEs
loaded with a drug. We propose a research plan that will move these technologies forward in the non-human
primate as an important translational step to humans. We first propose to develop an ultrasound transducer
that will decrease the focal spot size including receive elements that will allow us to map particle activation
through the skull. We will integrate the transducer into a FUS neuromodulation system built by our team under
the BRAIN Initiative and develop open-source software that will improve treatment planning for FUS
neuromodulation. We will apply this system to open the BBB in the sensorimotor region by activating PSNEs,
driving the resultant microbubble and injecting the inhibitory drug GABA, which does not cross the unopened
BBB in concentrations high enough to inhibit neurons. Because opening the BBB is not desirable in many
scenarios, we will also develop activatable drug-loaded PSNEs to locally deliver the anesthetic sodium
pentobarbital without opening the BBB. We will characterize the inhibitory effect of both neuromodulation
methods using BOLD fMRI and assess safety using neuroimaging and behavioral analysis. Our
multidisciplinary team has all expertise for MR-guided FUS with fMRI feedback and will collaborate with co-
investigator Dayton whose laboratory developed a condensation-based PSNE formulation that uses the same
excipients as commercially approved contrast agents. The acoustic technologies we propose to develop would
improve the spatial capabilities of FUS neuromodulation and explore two approaches for focal pharmacological
neuromodulation in the monkey including safety assessments that pave the way for translation.

Public health relevance
Project Narrative Focused ultrasound (FUS) neuromodulation will be combined with real-time MRI guidance and fMRI feedback to develop acoustic technologies (hardware, software, and activatable particles) for focal pharmacological neuromodulation of the monkey sensorimotor system. Safety will be monitored longitudinally and post-mortem. The proposed developments will improve the spatial capabilities of FUS neuromodulation, expand its use to focal pharmacological modulation, and provide key data to translate this technology to humans.